Environmental influences on Child Health Outcomes (ECHO) Coordinating Center

OVERALL ABSTRACT
Child health is determined by multiple environmental forces; however, surprisingly little is known about the
interactions of these forces. In addition, despite an emerging consensus that numerous gene-environment
interactions determine child health, much remains unknown about how genetic and environmental factors
combine to promote or prevent adverse outcomes. This Environmental influences on Child Health Outcomes
(ECHO) Coordinating Center (CC) proposal seeks to further strengthen the broad children's health research
community to increase the body of knowledge about these complicated effects by fostering collaboration
among internal and external stakeholders and supporting the research of the ECHO Program to enhance the
health of children for generations to come. The Duke Clinical Research Institute (DCRI) is uniquely positioned
to serve as the ECHO CC after successfully serving as the ECHO CC for the last seven years. In addition,
DCRI manages >30 active network and administrative coordinating centers and has emerged as a leader in
pediatric research. Unique features of the proposed ECHO CC include: 1) extensive experience and track
record of the leadership team in the support of the initial ECHO Program and conduct of multiple pediatric
studies; 2) pediatric operational expertise of the DCRI; and 3) existing, robust administrative infrastructure
necessary to effectively and efficiently manage responsibilities for coordinating the ambitious efforts of the
ECHO Program. The team is led by Drs. P. Brian Smith and Linda Adair. Dr. Smith is a neonatologist and an
accomplished pediatric researcher and leader of networks. He served as PI of the ECHO CC since its
inception seven years ago. Dr. Adair is internationally renowned for leadership of long-term pediatric cohort
studies. Dr. Adair has been instrumental in multiple leadership roles in the ECHO Program over the last six
years including oversight of the ECHO Opportunities and Infrastructure Fund (OIF), and roles in protocol
development and implementation, training, and publications. The specific aims for the ECHO CC are to: 1)
provide organizational infrastructure to coordinate and oversee ECHO Program's research activities; 2) support
ECHO Cohort Committees and communication among all ECHO Program Components and stakeholders; 3)
manage the ECHO OIF and foster training of a diverse cohort of investigators through an inclusive research
environment. The ECHO CC will establish and oversee the required infrastructure to coordinate the multiple
levels of membership in the ECHO Program. This infrastructure will focus on methods of learning valuable
information about environmental exposures through aggregation of massive amounts of data from ECHO
Cohort Study Sites. The ECHO CC will make scientific efforts faster and more efficient while protecting human
subjects. This infrastructure is possible because of the expertise of DCRI, which not only has extensive
experience in coordinating pediatric studies but also has the essential platforms ready.

Public health relevance
OVERALL PROJECT NARRATIVE Well-designed research is urgently needed to examine the impact of environmental exposures on health outcomes in children. The Duke Clinical Research Institute (DCRI) proposes to leverage its resources as the world's largest academic research organization to continue its success serving as the administrative hub and Coordinating Center of the Environmental influences on Child Health Outcomes (ECHO) Program.